Alliance of Randomized Trials of Medicine vs Metabolic Surgery in Type 2 Diabetes - (ARMMS-T2D)

ABSTRACT
The short-term safety and efficacy of bariatric/metabolic surgery for the initial remission of type 2 diabetes
(T2D) in patients with moderate to severe obesity is well established. However, there are no prospective
randomized controlled trials (RCTs) that have tested long-term efficacy, durability, and safety of this approach.
Moreover, Level-1 evidence regarding the risks and benefits of bariatric/metabolic surgery in patients with
diabetes and only mild obesity is limited. In this context, four investigative groups (Cleveland Clinic, Joslin
Diabetes Center/Brigham & Women's Hospital Boston, the University of Pittsburgh, and the University of
Washington) have completed RCTs that evaluated the short-term (1-3 years) effectiveness of
bariatric/metabolic surgery compared to multidisciplinary medical and lifestyle management of T2D and body
weight, including among patients who are only mildly obese or merely overweight. Investigators from these
four RCTs have now formed the Alliance of Randomized Trials of Medicine versus Metabolic Surgery in Type 2
Diabetes (ARMMS-T2D) consortium. With the support of an NIH U34 planning grant, we have prepared this
U01 application to obtain long-term follow-up data from 302 patients with T2D and a BMI of 27-45 kg/m2 (35%
with baseline BMI <35 kg/m2), who were randomized to surgical or non-surgical diabetes management
approaches. These RCTs include a set of common measures, and all of them have completed and published
at least one-year follow-up assessments. Through the U34 mechanism, we merged study participants and
harmonized study procedures and outcome metrics into a unified, prospective, longitudinal, observational
framework, and to date, we have successfully enrolled 244 participants into a short-term 2 year follow-up. The
primary goal of this U01 is to determine long-term (7-year) durability of glycemic control (percentage change in
HbA1c from baseline) following random treatment allocation to bariatric surgery or medical/lifestyle intervention.
Secondary outcomes include rates of diabetes remission and relapse, efficacy outcomes including fasting
plasma glucose, body weight, blood lipids, blood pressure, albuminuria, macro- and microvascular events,
cardiometabolic risk score, and quality of life, and safety including hypoglycemia and major cardiovascular
events. In exploratory analyses, we will identify clinical predictors of diabetes remission and relapse. Our
large, unified cohort will form the first RCT to address these questions, and it represents a cost-effective way to
generate essential long-term data. ARMMS-T2D is expected to have high impact because it will provide the
largest body of long-term Level-1 evidence to inform decision-making regarding comparative durability,
efficacy, and safety of bariatric/metabolic surgery relative to medical/lifestyle management of T2D among
patients with mild to moderate obesity.

Public health relevance
PROJECT NARRATIVE The short-term safety and efficacy of bariatric surgery for the remission of type 2 diabetes is well established; however, there are no prospective randomized controlled trials that have evaluated the longer-term durability and efficacy. The Alliance of Randomized Trials of Medicine versus Metabolic Surgery in Type 2 Diabetes (ARMMS-T2D) consortium will provide long-term Level-1, evidence-based data on diabetes remission and related outcomes that will guide clinical practice for patients with diabetes and mild to moderate obesity.